Registration Development Program for LUCEMYRA (Lofexidine) Label Expansion for Opioid Withdrawal Treatment in Adolescents

PROJECT SUMMARY:
An alarming increase in the rate of opioid abuse among the general population has resulted in a public health
emergency since 2017. The striking rise in opioid use disorder has affected Americans broadly, including steady
increases in adolescent deaths due to opioid overdose. However, a number of barriers exist for adolescents to
gain access to treatment; and current approaches to pharmacotherapy rely on the off-label use of opioids and
other agents used in adults with OUD.
Through a successful collaboration with NIDA, USWM developed lofexidine for the mitigation of opioid withdrawal
symptoms in adults. The Food and Drug Administration (FDA) approved lofexidine tablets (LUCEMYRA®) for
this indication in May 2018. Due to the anticipated utility of lofexidine for the treatment of opioid withdrawal in
children, USWM has completed all nonclinical prerequisites necessary to initiate studies in adolescents and
engaged with FDA to confirm the approach to registration.
The goal of this project is to further NIDA-USWM collaboration to complete FDA development requirements for
the approval of Lucemyra in adolescents. The use of an approved medication for opioid withdrawal will provide
needed safe and effective treatment options for this underserved patient population to optimize opportunities for
initial engagement in treatment and transition to longer term maintenance treatment options, including
buprenorphine and extended-release naltrexone, recommended in current guidelines. The proposed research
leverages an efficient regulatory pathway using a full extrapolation approach wherein pharmacokinetic (PK)
modeling can bridge established adult efficacy to adolescents through lofexidine exposure matching. The
approach requires a PK study in adolescents experiencing acute opioid withdrawal to identify Lucemyra doses
producing exposures associated with efficacy in adults, and an open label safety study to provide adequate
safety data in support of registration requirements. Key components of the program include: i) completion of a
Phase 1 PK in adolescents to complete efficacy requirements through exposure matching pediatric extrapolation
principles (UG3 Aims 1, 2) and completion of a formal FDA meeting to confirm the remaining scope of the
development program (UG3 Key go/no go Milestone), and ii) completion of a Phase 2 open label safety study
which, together with the initial Phase 1 study, can be integrated to satisfy the safety package requirements for a
supplemental new drug application (UG3 Aim 3, UH3 Aims 1 & 3).

Public health relevance
PROJECT NARRATIVE: The nation’s opioid epidemic has remained a public health emergency since 2017, with a steady increase in opioid misuse and deaths among Americans, including adolescents, a particularly underserved opioid use disorder (OUD) population due in part to a lack of approved medications. The proposed research program will enable submission of a supplemental new drug application for Lucemyra (lofexidine), currently FDA approved for opioid withdrawal in adults, to expand approval to adolescents and presenting a treatment option to facilitate patient engagement in therapy and transition to longer term maintenance treatments such as buprenorphine or extended-release naltrexone, as recommended by current adolescent treatment guidelines. Extrapolation of adult efficacy to the adolescent population permits an efficient regulatory path for this work, with two studies planned to complete registration requirements: i) a pharmacokinetic study in adolescents to identify doses producing lofexidine blood concentrations associated with efficacy in adults, and ii) an open label safety study to complete an adequate safety package for approval in adolescents.